Improving the Efficacy of Allogeneic Cell Therapies of Cancer

PROJECT SUMMARY
While chimeric antigen receptor (CAR) T-cells can be very effective in advanced hematological malignancies,
autologous products often have variable potency and require complex and expensive manufacturing, limiting
their scalability and accessibility. The long-term goal of this proposal is to develop a well-characterized, ‘off-
the-shelf’ (OTS) therapeutic T-cell platform using banked T-cells pre-manufactured from healthy donors, thus
offering immediate availability and high potency at a reduced cost. One major limitation of this approach is
potential immune rejection of infused OTS T-cells by host T- and NK-cells, which would impair persistence and
clinical benefit of the T-cell therapy. Therefore, my graduate dissertation project (Aim 1) focuses on engineering
OTS therapeutic T-cells to resist host immune rejection. I have developed the ‘first-in-class’ chimeric
alloimmune defense receptor (ADR) which enables allogeneic OTS CAR T-cells to defend themselves by
selectively eliminating activated host alloreactive lymphocytes while sparing other resting non-alloreactive cells.
T-cells co-expressing a 4-1BB-directed ADR and a CAR evade immune rejection and produce long-term anti-
tumor activity in mouse models of OTS CAR T-cell therapy for both liquid and solid tumors. We are now
optimizing the 4-1BB-specific ADR for clinical translation and will initiate a Phase I clinical study in our center. I
am also exploring other potential ADR targets, including OX40 and CD40L, to maximize the anti-rejection activity.
In addition to alloimmune rejection, activity of OTS T-cells in solid tumors can be inhibited by the
immunosuppressive tumor microenvironment (TME). Mounting evidence suggests that the inflammatory milieu
created by therapeutic T-cells may elicit reactive changes both locally (in the TME) and systemically (in
circulation) that further inhibit anti-tumor activity of therapeutic T-cells and possibly promote tumor growth and
metastasis. Examples include a surge of immunosuppressive M2-like macrophages in neuroblastoma patients
receiving GD2 CAR T-cells and poor responses to CD19 CAR T-cell therapy in patients with high circulating
myeloid-derived suppressor cells. In addition, preclinical studies indicate that treatment-induced inflammation
enhances pre-metastatic niche (PMN) formation and increases the risk of metastasis. Therefore, during my post-
doctoral training (Aim 2), I will first elucidate the reactive changes (both in TME and in circulation) caused by
therapeutic T-cells and identify cellular/molecular mediators of enhanced immunosuppression at the primary
tumor site. I will also investigate how T-cell therapies may affect PMN formation in solid tumors. I will then further
modify therapeutic T-cells to counteract these unwanted responses by arming them with secreted factors
(antibodies, peptide inhibitors) to block the responsible cytokines / chemokines, or by enabling them to selectively
eliminate inhibitory cellular subsets in the TME.
Successful completion of both Aims will ultimately improve the efficacy of OTS T-cell therapies of cancer.

Public health relevance
PROJECT NARRATIVE The proposed study aims to solve critical limitations of adoptive cell therapy of cancer by facilitating the development and evaluation of “off-the-shelf” engineered anti-tumor T-cells that will a) resist host immune rejection and b) withstand the immunosuppressive microenvironment of solid tumors. In the F99 phase, I will modify therapeutic T-cells to selectively recognize and eliminate alloreactive lymphocytes via an alloimmune defense receptor (ADR), and in the K00 phase I will identify key changes in tumor microenvironment in response to T-cell activity to further engineer therapeutic T-cells for optimal performance in solid tumors. Successful completion of this proposal will inform the development of next-generation banked T-cell therapies that are safe and effective in cancer patients.